Lung Immunopathology Training

Abstract
This competing renewal application is for continued support of an NHLBI (Lung Division) Post-Doctoral Training
Grant, which is currently in its 35th year at the University of Michigan Medical School, Department of Pathology.
The aim of this program is to provide in-depth training in basic and translational research to individuals that have
successfully completed MD, PhD, or DVM degrees. The research areas of focus include lung inflammation
(mediators and regulators), DNA repair, lung developmental biology, epigenetic pathways, immunopathology
(including the roles of oxidants, proteases, cytokines), and cell biology. The pathogenesis of a number of
pulmonary diseases is emphasized in our training program such as sepsis (ARDS), fibrosis, infectious disease,
and asthma. At inception, the program was led for 25 years by Professor Peter Ward. Dr. Nicholas Lukacs took
over as director in its 26th year. This experimental pathology program has extended to strong investigators in
other departments throughout the University of Michigan Medical Center, including Pediatric pulmonary, Cell and
Developmental Biology, Adult Pulmonary, Trauma Surgery, Allergy, and Microbiology/Immunology. In this
renewal we have further expanded the scope, adding not only new faculty trainers, but also the scientific
expertise that will allow our program to examine epigenetic, metabolic, and developmental control of the
inflammatory and pathogenic responses during lung disease. This expansion will serve to strengthen and
enhance the training program. Trainees are able to interact easily between laboratories due to the close
collaborative interactions between preceptors, further enhancing collaborative and training experiences. This
program has had the distinction of training an impressive number of post-doctoral researchers, M.D. and Ph.D.
that have gone onto strong academic and research careers. The setting of this program in the context of a large
and diverse academic medical center provides special advantages to trainees related to relevant research
endeavors of the preceptors that are closely linked to clinical disease. This latter aspect of translational research
effort is central to the efforts at the University of Michigan Medical School. Thus, this T32 has a proven record of
training researchers and will continue to successfully train post-doctoral fellows in research related to lung
diseases that effect large numbers of patients.

Public health relevance
Narrative The Lung Immunopathology T32 Program at the University of Michigan has been in existence for nearly 35 years and has placed >95% of trainees into Research careers. The program includes leading pre-clinical and translational researchers that together have strong funding and training records to allow the supported fellows to progress in their research careers that will provide future leaders in address pulmonary and immunology associated diseases.